SARS-CoV-2 infection and MHC class I function in bats

Project Summary
COVID-19 is a dangerous pandemic disease caused by the highly infectious coronavirus
SARS-CoV-2, which arose by zoonotic transfer from bats. CD8-positive T cells contribute to
viral elimination by killing infected cells, preventing viral expansion in an infected individual and
limiting the exposure of others to infection. CD8-positive T cells kill virally infected cells by
recognizing Major Histocompatibility Complex class I (MHC-I) molecules on their surface that
are associated with peptides derived from viral proteins. Like many viruses, SARS-CoV-2
encodes specific proteins that affect surface expression of MHC-I-peptide complexes, resulting
in resistance to T cell-mediated killing. We hypothesize that, since SARS-CoV-2 transferred
from bats to humans, its MHC-I inhibitory properties evolved in bats. We further hypothesize
that, because evolutionary pressure on the virus was mediated by natural selection in the face
of chronic exposure to the bat immune system, inhibition of MHC-I function will be more efficient
in bats than in humans. Investigating these hypotheses is limited by the lack of appropriate
reagents. This proposal seeks to remedy the situation by developing antibodies in mice and
rabbits and nanobodies in yeast that identify bat MHC-I proteins as well as the bat equivalents
of the additional human gene products that facilitate the generation and surface expression of
MHC-I molecules containing bound antigenic peptides, namely TAP1 and TAP2, tapasin,
calreticulin and the thiol oxidoreductase ERp57 (PDIA3). As we produce these reagents we will
use them to characterize MHC-I-restricted antigen processing in bats and determine how
SARS-CoV-2 infection affects it. We have identified four SARS-CoV-2 proteins that
independently cause MHC-I down-regulation in humans, and we suggest that these proteins
acting in combination are responsible for the reduction in MHC-I surface expression in infected
cells. Our goal is to determine whether these gene products, and potentially others, affect the
same process in bat cells and how well they do it. Understanding MHC-I function and adaptive
immunity in bats will help us to uncover why they are a such potent reservoir for coronaviruses.
Determining how bats survive infection by such viruses may suggest targeted therapeutic
approaches to improve the ability of humans to resist them and enhance our ability to control
and defeat future coronavirus pandemics.

Public health relevance
Project Narrative COVID-19 is a major public health emergency. The causative virus, SARS-CoV2, is highly contagious, producing a serious, even deadly, disease in many people, and is endemic to bats. This project seeks to understand the mechanisms the virus uses to evade T cell immunity and facilitate its persistence in bats, with the goal of enhancing resistance to the virus in humans.